Texas Animal Feed Regulatory Program Standards Maintenance and Preventive Controls Initiative

Abstract:
Texas Animal Feed Regulatory Program Standards Maintenance and Preventive Controls
Initiative
The Office of the Texas State Chemist (OTSC) is the designated state agency that oversees the
regulation of animal feed including sample analysis. Specifically, OTSC is comprised of the Texas
Feed and Fertilizer Control Service (FFCS) which is the regulatory agency and the Agricultural
Analytical Service (AAS) which analyzes regulatory samples for FFCS and the Food and Drug
Administration. During the past 5 years, OTSC has fully implemented the eleven standards,
achieved ISO 17025:2017 accreditation, created a document management system and is utilizing
the system for AFRPS implementation. During the next 5 years, OTSC will more fully integrate
AFRPS through a number of activities including exploring how the PCAF regulations could be
incorporated into Texas Commercial Feed Rules, building a more robust facility risk ranking matrix
and analysis platform, expanding audits to focus on PCAF and CGMP inspections, utilize feed-
related illnesses or death data in the risk ranking matrix, continue to evaluate industry compliance
through the enforcement matrix, expand outreach content and audience and incorporate
Laboratory Flexible Funding Model program samples into the OTSC annual plan of work. OTSC
will expand the number of qualified field investigators who can perform PCAF inspections by
seven who will be supported by a Preventive Control Qualified Field Inspection Trainer and
Auditor. An expanded educational outreach program will include development of new content
including probability charts for hazards by feed type identified in the FDA Guidance #245, model
plans, and annual updates of the status of the Texas feed industry involving risks associated with
these hazards. Two new courses will be developed and delivered in a face-to-face and online
format to the Texas feed industry and beyond and are titled: Food Safety Plan Development and
Verification and the second titled Auditing a Food Safety System. These courses will include the
new content listed above and class room exercises enabling participants to complete or revise
their food safety plan, verify its ability to manage risk including verification of control measures
including prerequisite programs and preventive controls. OTSC field investigators, equipped with
this new information, will practice educating while regulating during non-FDA inspections of
commercial feed facilities. These activities will be entered into a feedback loop to continually
improve the training based on new information and participant feedback.

Public health relevance
Narrative: Texas Animal Feed Regulatory Program Standards Maintenance and Preventive Controls Initiative During the next 5 years, OTSC will more fully integrate AFRPS through a number of activities including exploring how the preventive controls for animal food regulations could be incorporated into Texas Commercial Feed Rules, building a more robust facility risk ranking matrix and analysis platform, expanding audits to focus on PCAF and CGMP inspections, utilizing feed-related illnesses or death data in the risk ranking matrix, continue to evaluate industry compliance through the enforcement matrix, and incorporating Laboratory Flexible Funding Model program samples into the OTSC annual plan of work. OTSC will expand the number of qualified field investigators who can perform PCAF inspections by seven who will be supported by a Preventive Control Qualified Field Inspection Trainer and Auditor and offer new outreach programs.